Methods Core

The goal of the Methodologic Core is to support high-impact clinical research focusing on the
diagnosis, treatment, and prevention of musculoskeletal diseases. Specifically, the
Methodologic Core will provide the contemporary data science infrastructure necessary for
studies that leverage electronic health records (EHR), and for trials that collect patient reported
outcomes. We will organize around two major themes encompassing multiple activities:
confirmatory learning which includes design and analysis of observational studies and
randomized trials; and predictive learning which leverages contemporary machine learning and
artificial intelligence for processing electronic health records data and other high-dimensional
information. The data sciences are driving innovation in clinical research with the linkage of
multiple EMR systems opening new opportunities for large-scale clinical learning. Ultimately
rigorous research demands new methods for the extraction of reliable information and requires
the design of trials that can tailor to the unique characteristics of patients and the context of
health care delivery systems. The University of Washington Center for Biomedical Statistics
(CBS) has provided informatics and statistical leadership to multiple observational and
randomized studies focusing on musculoskeletal disorders and is uniquely positioned to provide
the foundation for expanded impact within the broad scope of the NIAMS mission.